Southeast Center for Health Achievement and Growth in Equity (SEACHANGE) Hub

ABSTRACT
The mission of the SouthEAst Center for Health Achievement aNd Growth in Equity (SEACHANGE) Hub is
to promote health equity and reduce the burden of disease in underserved populations by working hand-in-
hand with Community-Led, Health Equity Structural Intervention (CHESI) Projects and the ComPASS
Coordinating Center. The proposed hub harnesses the expertise of nationally recognized scholars to tailor
support services and contextual guidance to build CHESI research capacity and develop sustainable
interventional models.
Led by Caroline Compretta, PhD, the SEACHANGE Hub consists of team members from seven primary
institutions located in three contiguous states in the Southeast (the University of Mississippi Medical Center,
Mississippi State University, Tougaloo College, University of Southern Mississippi, University of Alabama at
Birmingham, Tulane University, and Louisiana State University). Its Multidisciplinary Expert Panel also
represents six additional institutions from across the country (Tuskegee University, Southern Poverty Law
Center, Carolina Central University, University of Central Arkansas, Brown University, and Mayo Clinic).
The SEACHANGE Hub comprises four units: an Administrative and Coordinating Unit, a Research
Methods and Data Management Unit, a Research Capacity Building and Training Unit, and a Community
Engagement and Health Equity (CEEQ) Practice Unit. In addition to its Multidisciplinary Expert Panel, the
SEACHANGE Hub will be guided in its work by a Community Advisory Board and two evaluators from Social
Grove, Inc.
Members of the SEACHANGE Hub will work closely with the CHESIs it has been assigned and actively
participate as a member of the ComPASS Program, including its Coordinating Center (CCC), Steering
Committee, and local and national Health Equity Research Assemblies. The Research Methods and Data
Management Unit will work closely with the CCC to harmonize data elements and management, and provide
tailored scientific support and technical guidance for its assigned CHESIs. The Research Capacity Building
and Training Unit will coordinate, design, and deliver tailored research and training support to its assigned
CHESIs and share the programs it designs with the CCC and other Hubs. The CEEQ Practice Unit will provide
tailored support to each of the CHESIs assigned to the SEACHANGE Hub to effectively implement community
outreach and engagement strategies and develop and implement its CEEQ Scholars Program. The
Administrative and Coordinating Unit will coordinate the work of the SEACHANGE Hub’s MEP, Community
Advisory Board and its units to ensure coordination of efforts.

Public health relevance
PROJECT NARRATIVE The impetus for the ComPASS Program is the increasing recognition that advancing health equity is a complex challenge that extends beyond the reach of traditional healthcare settings, organizations, or research agendas. This NIH-wide program was created to foster efforts to address structural causes and pathways of differential health outcomes, with the goal of reducing health disparities across diseases and conditions among populations that experience them. The proposed SEACHANGE Hub would participate as one of five hubs in a program that also includes 25 Community-led, Health Equity Structural Intervention (CHESI) projects throughout the U.S. and one Coordinating Center.